Promoting HPV Vaccination among Young Adults in Texas

PROJECT SUMMARY/ABSTRACT
Parent Grant: Human Papillomavirus (HPV) incidence is disproportionally high among adolescents and
young adults aged 15-24 years. The Centers for Disease Control and Prevention (CDC) recommends “catch-
up” vaccination for young adults through 26 years. However, young adults, specifically college students, continue
to display alarmingly low rates of HPV vaccination. The parent grant aims to develop and test a multilevel
narrative-based intervention designed to address individual- and system-level factors to increase school-based
vaccine access and HPV vaccine uptake among Texas college students. Proposed Diversity Supplement:
This supplement will benefit the parent grant research by examining interpersonal influences on HPV vaccination
decision-making that exist between the individual and system levels of influence as denoted in the parent grant
and the Social Ecological Model. Importantly, parents and friends are often cited as the most influential people
in vaccine decision-making among young adults. However, parents and friends can be perceived to express
HPV vaccine disapproval, which can result in increased stigma surrounding the HPV vaccine. In this supplement,
we will: (1) identify sociodemographic and psychosocial predictors of perceived HPV vaccine disapproval from
family and friends (Aim 1); (2) examine how perceived HPV vaccine disapproval impacts both the behavioral
skills needed to vaccinate against HPV and the stages of HPV vaccine decision-making (Aim 2); and (3) test
the parent grant intervention’s ability to reduce perceived HPV vaccine disapproval from family and friends and,
consequently, reduce HPV vaccination disapproval at follow-up (Aim 3). We will perform secondary data analysis
using baseline and follow-up data from the parent grant. Block-sequential multivariate regression will be
performed to determine sociodemographic and psychosocial predictors of HPV vaccine disapproval from parents
and friends (Aim 1). Multinomial logistic regression will be used to test whether perceived HPV vaccine
disapproval from family and friends is associated with an increased likelihood of being in the earlier stages of
HPV vaccine decision-making. A path analysis will be performed to examine the impact of perceived disapproval
from family and friends on HPV vaccination intentions through different behavioral skills (e.g., self-efficacy and
information-seeking; Aim 2). Finally, both linear and logistic regression mediation analysis will be performed to
examine whether the intervention is associated with decreases in perceived HPV vaccine disapproval from family
and friends, which, in turn, decreases HPV vaccination disapproval at 3-month follow-up (Aim 3). Ultimately, this
work will benefit the parent grant by identifying groups of college students who experience high levels of
perceived vaccine disapproval/stigma from important others and, thus, are at high risk of being vaccine-hesitant
and/or “stuck” in their HPV vaccination decision-making. In addition, this work may highlight the benefits of
tailoring the parent grant intervention to college students who perceive interpersonal barriers to HPV vaccination.

Public health relevance
PROJECT NARRATIVE HPV incidence rates are high among traditional college-aged adults (i.e., young adults aged 18-26 years) – a population that continues to display alarmingly low rates of HPV vaccination (i.e., <60% of all U.S. college students have received the first dose of the vaccine). We expect this diversity supplement project will: (1) identify factors associated with interpersonal barriers to HPV vaccination, specifically perceived HPV vaccine disapproval from friends and family; (2) provide important insights into how perceived HPV vaccine disapproval from important others impacts the HPV vaccine decision-making process; and (3) highlight the ability of the parent grant’s multilevel narrative-based intervention to decrease perceived HPV vaccine disapproval from important others and, consequently, increase HPV vaccine uptake among college students. It is expected that this diversity supplement project will have a significant impact on future intervention implementation approaches that address the most influential interpersonal relationships (e.g., parents and friends) to increase HPV vaccination uptake among young adults, specifically college students.